To establish the BC Cancer Agency - Vancouver Centre as a major SWOG centre

The purpose of this application is to request a grant to support the BC Cancer Agency - Vancouver in becoming a major SWOG centre. The application provides justification and information to support our grant application.

Public health relevance
Inclusion of the BC Cancer Agency Vancouver Cancer Centre as a SWOG member would give BC patients access to a much broader range of clinical trials, with the potential to significantly improve their outcomes. A successful membership application would also benefit the wider SWOG group by enhancing accrual to Group trials, and providing access to the Agency's outstanding clinical trials resources and infrastructure.